The role of glial-glial interactions during oligodendrocyte tiling

ABSTRACT
The development of an efficient nervous system is contingent upon the differentiation and proper organization
of billions of glia in the central and peripheral nervous systems (CNS and PNS, respectively). As
neurodevelopment progresses, glial cells communicate with their neighbors to proliferate, migrate, and establish
non-overlapping territories – a process termed glial tiling. Oligodendrocyte lineage cells (OLs) are a glial
population that must spread throughout the CNS by tiling. However, the cellular and molecular mechanisms that
orchestrate OL tiling remain unclear. Previous data from our lab implicates Met signaling as a key regulator of
OL migration. Here, using genetic mutation, endogenous knock-in techniques, and live confocal imaging, I will
elucidate the phenotype of hgf knockout, identify the source of Hgf secretion, and reveal potential glial-glial
interactions that drive OL dorsal migration. Genetic manipulation and cellular ablation assays will further reveal
the temporal requirements and sufficiency of Hgf signaling during OL migration. To identify additional mediators
of OL tiling, I turned to single nuclei RNA sequencing datasets and identified the cell adhesion molecule, Dscamb,
as highly upregulated in pre-myelinating OLs. Using full body and cell-type specific mutagenesis techniques, I
will investigate the role of dscamb during proliferation and contact mediated repulsion of OLs. OL-OL interactions
and OL-MEP glia interactions will be examined by live confocal imaging when dscamb is genetically perturbed.
Lastly, I will investigate the dosage effects of dscamb by overexpressing the gene in specific cell types. Together,
these studies will provide insight into how glia communicate with one another to pattern the developing nervous
system.

Public health relevance
PROJECT NARRATIVE During neurodevelopment, glia must space apart from one another to occupy discrete, nonoverlapping territories in which they carry out their own unique functions. The process of glial tiling is critical for the establishment of an efficient nervous system, however the cellular and molecular mechanisms that regulate tiling remain unclear. In the following proposal, I aim to investigate Hgf and Dscamb as molecular mediators of oligodendrocyte lineage cell (OL) migration and contact mediated repulsion, respectively, to elucidate mechanisms of OL tiling and shed light on the importance of glial-glial interactions during development and disease.